Digital health platform (DHP) to deliver Mindfulness as a Stress Management Intervention Leveraging Electronic (SMILE) health records for racial and ethnic populations during the COVID-19 pandemic

PROJECT SUMMARY/ABSTRACT
The current COVID-19 pandemic is disproportionately affecting Black and Latino individuals and increasing
existing health disparities. These racial/ethnic populations are facing magnified stress and lack access to patient-
oriented health services. Thus, utilization of Digital Health Platforms (DHP) has the potential to address reach,
delivery, effectiveness, scalability, and sustainability to decrease COVID-19 related stress in these populations.
The proposed study builds on our previous DHP, the Biofeedback Assisted Resilience Training (BART), that
targeted improving physiological metrics of Heart Rate Variability (HRV) as a measure of autonomic regulation
to manage stress in service members. Now, we incorporate UNC Health patient portal (UNCH- PHRs),
Mindfulness-Based Stress Reduction program tailored for COVID-related stress, wearable heart rate sensor,
and mobile health app (mHealth) to collect physiological and psychological scales of mental health, into our DHP
model to deliver a culturally sensitive Stress Management Intervention Leveraging Electronic health records
(SMILE).
The overall objective of this proposal is to investigate effectiveness and sustainability of our DHP model, to
delineate mindfulness-related mechanisms of action by measuring changes in psychological self-reported
metrics and autonomic balance using HRV, and to examine associations between COVID-19 related stress and
mental health outcomes, resilience, and HRV. Understanding these interrelationships with a focus on
racial/ethnic groups is of utmost importance to provide personalized treatment. The central hypothesis is that
SMILE will mitigate COVID-19 related stress. We will test our central hypothesis with a 3-arm randomized
controlled trial. Participants will be randomized to one of three arms: 1) an internet-delivered, instructor-
administered Mindfulness-Based Stress Management training (MTIA), 2) self-administered Mindfulness training
through the commercially available mHealth app Headspace (MAPP), or 3) Waitlist control (WLC). The DHP will
capture progress at various points of the study (baseline, weekly during the 08 weeks and at 3-months follow-
up). Our rationale is that our DHP model enables access to a wide range of populations, facilitating the promotion
and delivery of targeted DHP interventions, such as mindfulness, while collecting psychophysiological metrics to
assess treatment efficacy and predictors of mental health. The broader impact is that our proposed DHP could
be used to assess new treatment effects and increase health equity for racial/ethnic populations.

Public health relevance
PROJECT NARRATIVE Digital health platforms (DHP) use computing technologies, connectivity, software, and sensors for health care. DHP have the potential to increase health equity for minority groups, the proposed innovative study evaluates a DHP model that leverages on a patient portal to engage race/ethnic groups, who has been disproportionally affected by COVID-19, digitally deliver an intervention (i.e., mindfulness) targeted to mitigate COVID related stress, and remotely collect self-reported psychological and physiological metrics of mental health and autonomic regulation. These findings have implications on precision medicine by providing access and remote/real-time report on the person’s health to offer a targeted intervention, while focus on increasing access to care for race/ethnic populations.